Avoiding (Heart) Failure: Physiologic-Based Targeting of the RAAS to Treat Subclinical HFpEF among PWH

Project Summary: Heart disease is a leading cause of non-communicable disease-related morbidity and
mortality in the well-treated HIV population, and heart failure with preserved ejection fraction (HFpEF) is rising
in prevalence. There are no FDA-approved therapeutics directed at HFpEF that effectively reduce morbidity
and mortality in HIV or the general population, which highlights an expanding population of patients with a
significant unmet clinical need. Early changes in myocardial structure and function are well-recognized among
asymptomatic persons with HIV (PWH), affecting 50-60% of the population. The exact mechanism precipitating
antecedent myocardial dysfunction, related to altered relaxation and increased stiffness and filling pressures of
the left ventricle, and subsequent progression to symptomatic HFpEF in HIV is unclear. Myocardial
inflammation and fibrosis are postulated to be substantial mediators of HFpEF and are mechanistically relevant
among PWH whom demonstrate chronic systemic inflammation and immune activation and metabolic disease
regardless of immunological control. Rigorous hormonal testing from our group among PWH show increased
renin-angiotensin-aldosterone system (RAAS) activation is relation to reduced natriuretic peptide (NP) and
increased inflammation and monocyte/macrophage activation. NPs have cardioprotective effects, and relatively
reduced NPs could impair activities related to natriuresis, vasodilation, myocyte hypertrophy, and fibroblast
proliferation, altering stability of the myocardium. We further postulate relatively reduced NP, a phenotype
shown in highly metabolic groups and now demonstrated for the first time in HIV, may allow permissive RAAS
activation leading to downstream inflammation and myocardial damage. We aim to investigate the cardiac
phenotype associated with reduced NP among PWH compared to uninfected individuals utilizing advanced CV
imaging techniques (cardiac MRI, cardiac TTE) and circulating myocardial biomarkers to comprehensively
assess myocardial inflammation, structure, and function. This novel proposal represents a substantial
departure from the typically well-studied HF patients with relatively higher NP and may uncover a large class of
newly-identified inflammatory-prone or metabolically-deranged patients deserving of more clinical attention in
the HF realm. We will also determine the effect of sacubitril/valsartan, a dual angiotensin II receptor antagonist
and neprilysin inhibitor, vs. placebo on longitudinal changes in myocardial inflammation, structure and function
among PWH in a 6-month randomized controlled trial. These studies apply a novel concept in studying PWH,
among whom we postulate a therapy to simultaneously increase NP and decrease RAAS activation may be
beneficial for heart disease based on unique RAAS-NP physiology in HIV. These studies led by an early stage
investigator and team of experts in HIV-associated CVD, CV imaging, HFpEF phenotyping, CV biomarker
science, and CV endocrinology will provide key insight on two neurohormonal systems critical to CV health,
RAAS-NP, and test whether targeted manipulation of these systems can reduce subclinical HFpEF risk in HIV.

Public health relevance
Project Narrative HIV is a chronic disease in which patients, even those well-treated, are at increased risk for heart disease when compared to the general population. Two hormones called aldosterone and brain natriuretic peptide (BNP), which have been shown to be abnormal in HIV, may be associated with inflammation as well as early changes in structure and function of the heart. This study is being conducted to evaluate whether therapies to block aldosterone and increase BNP levels may reduce the burden and progression of heart failure—an important public health issue to improve cardiovascular health.